Damage-associated molecular patterns in chemotherapy toxicity

Abstract
Paclitaxel, one of the most widely used antineoplastic drugs, is highly effective in treating a variety of
solid tumors, including breast and non-small cell lung cancer (NSCLC). However, the clinical use of paclitaxel is
limited by the development of dose-limiting paclitaxel-induced peripheral neuropathy (PIPN) by most cancer
patients who receive paclitaxel. Unfortunately, current strategies to prevent or treat PIPN are ineffective, and our
understanding of the molecular mechanisms underlying PIPN remains incomplete. In addition to directly
damaging neurons within the dorsal root ganglia (DRG), the site of injury for PIPN, paclitaxel also induces
neuroinflammation and the recruitment of immune cells to the DRG, which has recently emerged as a key driver
of PIPN; however, druggable targets within this cascade have remained elusive. In pursuit of our long-term goal
to decrease adverse events associated with paclitaxel, we have identified S100A9, an inflammatory damage-
associated molecular pattern (DAMP) with readily available pharmacologic inhibitors, as a candidate target to
reduce PIPN and neuroinflammation. In preliminary studies, we found that mice treated with paclitaxel developed
a PIPN-like phenotype and had upregulated S100A9 in their DRG. Functional validation studies in S100A9-
deficient and matched wild-type (WT) mice demonstrated that S100A9 deficiency protected mice from
neuropathy in both acute and chronic models of PIPN. Next, to elucidate whether the protection conferred by
deficiency of S100A9 is related to neuroinflammation involving immune cells recruited from the bone marrow,
we performed allogeneic transplant experiments and found that only mice with S100A9-deficient bone marrow
were protected from PIPN. To provide proof-of-principle and demonstrate the translational relevance of this
target, we found that multiple pharmacological inhibitors of S100A9 also protected against PIPN without affecting
paclitaxel’s plasma levels or its cytotoxic potential against multiple breast cancer cell lines. Based on these
preliminary findings, we now outline three sets of related studies that will further test and refine the validity of our
central hypothesis that targeted inhibition of S100A9 can reduce paclitaxel’s toxicity and downstream
neuroinflammatory cascade without negatively influencing its plasma pharmacokinetic profile or antitumor
properties: (i) characterize the mechanism underlying S100A9-induced PIPN, with an emphasis on neuro-
immune interactions; (ii) determine an optimal regimen to pharmacologically inhibit S100A9 and prevent PIPN
utilizing PK-PD modeling; (iii) safety, toxicokinetic, and efficacy analyses of an optimized combinatorial regimen
of paclitaxel and a pharmacologic S100A9 inhibitor with simultaneous assessment of protection from PIPN and
antitumor properties in established experimental models of breast cancer and NSCLC. It is expected that these
studies will shed new light on the etiology of PIPN and provide a rationale for the future implementation of a
novel targeted intervention strategy to prevent this debilitating side effect.

Public health relevance
Project Narrative Paclitaxel is one of the most effective and widely used anticancer drugs, but its clinical use is limited by the development of dose-limiting damage to peripheral nerves (peripheral neuropathy). Using unique genetic mouse models, we found that acute and chronic forms of paclitaxel-induced peripheral neuropathy (PIPN) are dependent on neuroinflammation mediated by S100A9, a damage-associated molecular pattern (DAMP) protein. The proposed studies are a logical continuation of our preliminary studies and will directly test the hypothesis that pharmacological inhibition of S100A9 can mitigate the incidence and severity of this debilitating side effect without negatively affecting the agent’s anticancer properties.